INTERFERON ALPHA 2B &ORAL RIBAVIRIN COMBINATION THERAPY FOR HEPATITIS C IN HIV

HIV-positive adult male and female study subjects will be recruited from Moore Clinic patients who have positive HCV antibodies and positive HCV RNA on stable antiretroviral regimens (>4week). Thirty (30) subjects will be selected for study participation according to inclusion and exclusion criteria in the clinical protocol.